Racism and Resilience Among Black Autistic Children and Caregivers

PROJECT ABSTRACT
Persistent, and quite pervasive, racial disparities have been found between Black, autistic children and their
White, autistic peers. These disparities range from notable inequities in the timeliness of diagnosis to receipt of
substandard services to their under-representation in research studies. While key disparities have been
documented, there is a need for increased attention on potential underlying drivers of these disparities that are
rooted in the Black experience. We know from existing research on Black health and wellness that racism is
linked to some poorer physical and mental health outcomes. Our team will examine the impact of racism and
resulting racial trauma on the mental health outcomes of Black parents of autistic children (ages 3 -9) as well
as the downstream consequences that parental racial trauma has on child behavior and development. Using a
mixed method, cross-sectional study design, we will recruit an economically heterogeneous sample of 300
Black parents / caregivers of autistic children in the states of NC and PA. We will also use a community-
partnered participatory framework to tell the whole story of Black risk and resilience by focusing on both racial
trauma as well as Black cultural capital and assets. Therefore, the specific aims of this project are: Aim 1:
Understand the impact of racism (i.e., everyday racism and racialized trauma) on the well-being (i.e., quality of
life, stress, caregiver strain) of Black parents of autistic children. Aim 2: Examine whether parents’ experiences
with racialized trauma adversely affects child behaviors and development. Aim 3: Determine cultural capital
factors that moderate the impact on racism on parental well-being. Exploratory Aim 4: Using moderated
moderation analysis, explore whether cultural capital factors and parental well-being both moderate the impact
of racism on child behaviors and development. We further seek to understand how Black parents of autistic
children support their children’s racial pride and acceptance.
This team is ideally suited to tackle the complex topics and intersectional identities associated with race and
disability. We bring relevant and culturally informed content and methodological expertise. Further, our work is
being conducted in partnership with the Color of Autism organization, a national organization designed to
support and empower Black families. Through this work, we will gain key insight and knowledge of how the
Black experience impacts rearing an autistic child of color to provide more specificity and direction for future
tailored intervention approaches. This research is likely to exert a significant and immediate impact on the field
because it examines both the risk and resilience of a historically marginalized and excluded group.

Public health relevance
PROJECT NARRATIVE Racial disparities in autism have been consistently identified, but we have failed to examine the role that racism plays in the lives and outcomes of Black parents and their autistic children. This study will use a mixed methods design to capture both breadth (using a large quantitative sample of 300 families) and depth (using focus groups) of the complex interactions of race, racism, class, disability, and cultural assets. This research is likely to exert a significant impact on the field because it examines both the risk and resilience of a historically marginalized group and informs future tailored intervention approaches by gaining key insight of how the Black experience impacts rearing an autistic child of color.